Targeting the retinoic acid signaling pathway for mitigating visual impairmen in retinal degenerative disorders

ABSTRACT – NO CHANGE TO PARENT AWARD
Light responses are initiated in rod and cone photoreceptors, processed by retinal interneurons, and synaptically
transmitted to retinal ganglion cells (RGCs), which send information, in the form of spike trains, to the brain. In
degenerative retinal disorders, including Age-related Macular Degeneration (AMD) and Retinitis Pigmentosa
(RP), the photoreceptors gradually die off, depriving downstream neurons of light-sensitive input. However,
recent evidence suggests that losing photoreceptors is only part of the problem in these disorders. Downstream
retinal neurons become hyperactive, with retinal ganglion cells (RGCs) firing spontaneously in darkness at up to
10 times faster than in healthy retina, corrupting the proper encoding of visual information. We recently reported
that retinoic acid (RA), a small molecule that activates gene transcription, is the signal that triggers RGC
hyperactivity. Blocking the receptor for RA in vivo can reverse hyperactivity, unmasking light responses that
would otherwise be obscured by spontaneous RGC firing. Blocking RA receptors in the retina also augments
the contrast-sensitivity of learned visual behaviors in a mouse model of RP. Our goal in this project is to assess
whether drugs or gene therapies that inhibit RA signaling can improve vision in mouse models of RP, with the
hope of extending useful vision for years in humans with degenerative retinal disorders. First, we will ask whether
inhibiting RA signaling not only improves light-sensitivity, but actually improves conscious visual function in
vision-impaired mice, assessed with behavioral tests of contrast sensitivity and spatial frequency threshold. We
will determine how when during the degeneration process RA inhibitors are most effective, revealing the optimal
time for beginning treatment. Second, we will investigate retinal neurons that lie upstream of RGCs, namely
bipolar cells and amacrine cells. We will ask whether pathophysiological changes in these presynaptic neurons
are also induced by elevated RA signaling and whether inhibiting RAR can reverse these changes, providing
critical information for effective cellular targeting of gene therapy. Third, we will test whether vision can be
improved by inhibiting the enzyme that synthesizes RA, with a re-purposed drug that is already FDA-approved
for other indications, paving the way for human clinical studies. Taken together, this project will establish the
proof-of-principle behind a new treatment paradigm for augmenting vision in retinal degenerative disorders.

Public health relevance
NARRATIVE – NO CHANGE TO PARENT AWARD Age-related Macular Degeneration (AMD) and Retinitis Pigmentosa (RP) are caused by loss of rod and cone photoreceptor cells, but other retinal also show changes, including the emergence of hyperactivity in many retinal ganglion cells (RGC). We recently discovered that retinoic acid (RA) is the signal that triggers RGC hyperactivity and that blockers of RA unmask light responses in RGCs that would otherwise be obscured. In this project, we will explore whether drugs or genes that inhibit either the production or action of RA can improve conscious vision in a mouse model of RP, providing a new strategy for enhancing low vision in human blinding disorders.